Capturing the Holistic Glycocode through Systems Glycobiology

PROJECT SUMMARY & ABSTRACT
The glycocode, or collection of holistic features arising from specific combinations of glycan and protein
biomolecules, is a currency used at the cell surface to exchange information and direct biological processes.
The unique molecular surfaces created by specific glycan-protein combinations are a critical axis of information,
yet they remain poorly understood due to numerous analytical challenges associated with studying their
complexity. Emerging evidence from immuno-oncology, virus pathobiology, and beyond underscore that this
blind spot can no longer be afforded.
This proposal generates a suite of new technologies to capture the combinatorial patterns of the
glycocode using innovations in mass spectrometry (MS) and chemical glycoproteomics. Together these will
enable systems-scale interrogation of the human glycocode. Aim 1 introduces a new platform for cell surface
glycoproteomics that retains glycan-protein patterns rather than relying on traditional protein-centric methods
that ignore the glycan component. By synthesizing novel chemical probes that append an easily enrichable
phosphonate handle to cell surface glycoproteins through live cell labeling, we provide a chemical
glycoproteomics platform for “catch-and-release” enrichment of intact glycoconjugates that provides access to
combinatorial glycocode features. Aim 2 accompanies our chemical glycoproteomics approach with advances
in the MS methods used to identify and quantify glycocode constituents (i.e., glycopeptides, glycoproteins, and
glycans). Through the use of real-time analyses to enable adaptive instrument control, we improve the sensitivity
and throughput of glycopeptide characterization. To complement bottom-up glycopeptide methods, we also
establish a novel top-down approach to fingerprint combinatorial glycocode modifications on intact glycoproteins
using ion-ion gas-phase chemistry to extract glycoform information from typically challenging denatured species.
In Aim 3, we leverage these tools to define a human glycocode atlas across 12 different cell types to connect
heterogeneous glycocode expression with specialized cellular functions. Furthermore, we extend this atlas to
investigate dynamic glycocode reprogramming during epithelial-mesenchymal transition to discover cell-type
specific signatures of migratory phenotypes that can be targeted in diagnostic and therapeutic strategies.
In all, this proposal represents a significant advance in chemical glycoproteomics and MS methods,
generates a long-needed resource for cell surface biology, and provides a robust foundation for me to build an
independent research career focused on glycocode regulation in human health and disease. Key to
accomplishing these aims will be training in chemical synthesis to make novel chemical glycoproteomic reagents
during the K99 phase, which will equip me with the skills necessary to execute my vision for chemical
glycoproteomics to investigate glycocode. Work proposed here will be fundamental in my transition to
independence and will establish me as a leader in the promising field of systems glycobiology.

Public health relevance
PROJECT NARRATIVE Molecular interactions at the cell surface are paramount to many biological processes, yet our knowledge of the cell surface architectures that dictate these interactions remains incomplete. This proposal introduces novel technologies to capture glycoprotein features across the cell surface proteome, where glycan and protein components contribute holistically to unique molecular surfaces that relay biological information (i.e., the glycocode). Using these developments, we will generate a human glycocode atlas across multiple cell types to explore the role of cell surface glycocode heterogeneity in specialized cellular functions, and we will study dynamic glycocode reprogramming as cells transition from sedentary to migratory phenotypes known to drive numerous pathologies.